Symposium on Obesity and Transplantation: Comparing Medical Nutrition Therapy, Pharmacotherapy, and Bariatric Surgery

PROJECT SUMMARY
Obesity continues to be a significant barrier to solid organ transplantation. Patients with obesity awaiting
kidney, liver, and heart transplantation are often delayed or denied transplants until weight loss is achieved.
We propose a research development conference to review and discuss the evidence-base and current
practices surrounding the use of medical nutritional therapy, pharmacotherapy, and bariatric surgery to support
patients' weight loss prior to solid organ transplantation. The proposed Symposium on Obesity and Solid
Organ Transplantation: The Role of Medical Nutrition Therapy, Pharmacotherapy, and Bariatric Surgery, will
convene a multidisciplinary group of clinicians, researchers and allied health professionals (i.e., social workers,
nutritionists, dieticians) in the fields of solid organ transplantation and obesity as well as patients with obesity
awaiting transplantation to develop an agenda for future comparative effectiveness research at the intersection
of these fields and develop strategies for reducing delays in the receipt of life-saving and life-changing
transplants and wait list mortality for patients with obesity. The proposed research development conference
builds on our successful AHRQ-funded Symposium on Obesity and Kidney Transplantation held in May of
2021 (R13HS028377). This inaugural hybrid event garnered 486 registrants and 317 attendees; the meeting
also generated 56 research questions and overwhelmingly positive reviews. The proposed conference
expands on this inaugural event and aims to: 1) elicit patient perspectives on and experiences with regarding
the challenges and successes of weight loss and management in preparation for kidney, liver and heart
transplantation; 2) provide a forum for sharing research findings and clinical experience related to the use of
medical nutritional therapy, pharmacotherapy, and bariatric surgery to address obesity prior to transplantation;
3) generate a research agenda, including specific research questions, to investigate issues related to obesity
and transplantation. We propose to organize, advertise, implement and evaluate the symposium, and
disseminate the resulting content in collaboration with our existing Steering Committee. In addition, three
patients who have been evaluated and waitlisted for kidney, liver, lung, or heart transplantation and who
concurrently suffer from obesity that is delaying transplantation will be recruited as patient partners to serve as
members of the Steering Committee. Three additional patient partnerss will serve as symposium panelists and
will share personal experience with weight loss as a transplant candidate to an audience of clinicians,
researchers and allied health professionals. Our anticipated outcomes include a manuscript from the
symposium content and discussions, and an agenda with specified research questions for future comparative
effectiveness research on the use of medical nutritional therapy, pharmacotherapy, and bariatric surgery to
treat obesity prior to solid organ transplantation.

Public health relevance
PROJECT NARRATIVE Obesity continues to be a barrier to transplantation for some patients with end stage kidney, heart, and liver disease. The proposed Symposium on Obesity and Solid Organ Transplantation: The Role of Medical Nutritional Therapy, Pharmacotherapy, and Bariatric Surgery will bring health services researchers, clinicians, allied health professionals and patients with obesity together to discuss current clinical practice, cutting edge research and patients' lived experiences. The meeting content and discussion will be used to develop a manuscript and an agenda for future comparative effectiveness research for future inquiry.